Implementation and Implications of Sickle Cell Trait Screening in the NCAA

ABSTRACT
In 2010 the National Collegiate Athletic Association (NCAA) adopted a mandatory sickle cell trait (SCT)
screening policy for student-athletes in its Division I (DI) colleges and universities. Currently, schools in all
three divisions of the NCAA are implementing the policy. To date, very little published research is available
on SCT in student-athletes or on the actual implementation of the NCAA screening policy. Many important
questions remain regarding this controversial mandated genetic screening program.
Results from a preliminary study we conducted of NCAA DI institutions in North Carolina reveal that
athletic staff at most of the schools found it beneficial to know the SCT status of their student-athletes, but felt
they need clearer guidance and instructions from the NCAA on the policy implementation. We also found that
that some athletic staff and student-athletes believed that black students were the only ones at risk and should
be the targets for screening. There has been little education for coaches, athletic trainers, and student-athletes
on reasons for screening all student-athletes. Of the few student-athletes with SCT in our sample, only about
one-half changed the way they participate in their sport based on their status. These and our other preliminary
findings provide important information concerning the procedures, perspectives, and behavioral outcomes at
some institutions in one US state. A larger and more representative sample is needed to better understand the
policy’s challenges, limitations, and risks, and to develop strategies to address them.
This proposal builds upon our previous work in North Carolina. The Specific Aims are to: 1) assess
implementation, risks, and secondary benefits of the NCAA SCT screening policy and determine contributors
to and implications of variation within these domains and 2) provide guidance on the current NCAA SCT
policy and practice and other similar public health policies and practices. For Aim 1, data will be generated
from online surveys and semi-structured telephone interviews with athletic staff and student-athletes at
NCAA DI, DII, and DIII colleges and universities. For Aim 2, we will collaborate with the NCAA to convene a
national summit involving selected stakeholders at institutional and policy levels to review the findings from
Aim 1 and develop best practice recommendations for future implementation of the SCT screening policy.
The proposed research will provide unprecedented and invaluable information on the procedures,
perceptions, and outcomes of the NCAA SCT screening policy. It will uncover real and perceived benefits,
risks, and effectiveness of the policy, and facilitate efforts to address the areas of concern. The project will also
establish a useful empirical foundation for decision-making concerning future implementation of the NCAA
policy and similar policies and programs aimed at preventing illness and protecting the public’s health.

Public health relevance
PROJECT NARRATIVE The sickle cell trait (SCT) screening program of the National Collegiate Athletic Association (NCAA) is regarded as one of the largest mandated genetic screening programs in the United States (US). Estimates suggest that over 2,000 NCAA Division I student-athletes with SCT will be identified under the screening policy and that, without intervention, about seven NCAA Division I student-athletes would die suddenly from a complication of SCT over a 10-year period. Our proposed project will facilitate the identification and resolution of issues that may impede the successful detection of SCT carriers and the application of effective interventions; it also aims to advance research and practice pertaining to the implementation of similar public health policies that target healthy subpopulations deemed to be at disproportionate risk.